Examining the Impact of Medicaid's Prior Authorization Requirements for Tobacco Cessation Medications on Tobacco Cessation Medication Prescriptions

PROJECT SUMMARY/ABSTRACT
Increasing access to tobacco cessation medications is a key part of U.S. health policy’s strategy for reducing
smoking, especially for low-income smokers, who are less likely to use tobacco cessation medications than
high-income smokers are. Given that the Affordable Care Act requires Medicaid programs to cover tobacco
cessation medications, Medicaid coverage grants enrollees access to tobacco cessation medications in
principle, but over two-thirds of state Medicaid programs require doctors to obtain prior authorization from
program administrators before prescribing tobacco cessation medications. While prior authorization
requirements’ advocates argue that requiring prior authorization can ensure appropriate and cost-effective
prescribing without reducing access to helpful medications, even small prescribing hurdles have the potential
to have large impacts on prescribing behavior and medication access. Public health leaders call for removing
barriers in access to tobacco cessation medications, but it is not currently known if requiring prior authorization
meaningfully reduces overall use of these medications or if it instead ensures appropriate use without reducing
access more generally, as its advocates argue. This project proposes to estimate the impact of prior
authorization requirements in Medicaid on the use of tobacco cessation medications by using detailed data on
health care claims to study Colorado’s Medicaid program removing its prior authorization requirement for
tobacco cessation medications in 2018. A primary objective of the proposed project is to estimate the impact of
Colorado removing its prior authorization requirement on overall tobacco cessation prescriptions and related
treatments. A second objective is to estimate heterogeneous impacts of removing prior authorization
requirements for different demographic groups. The project then proposes to use the estimates to conduct
additional analyses to assess the national implications of Medicaid programs requiring prior authorization for
tobacco cessation medications. In addition, the project proposes to test for heterogeneous effects of prior
authorization requirements based on prior health conditions to assess the claim that the main effect of prior
authorization requirements is to avoid prescriptions that Medicaid programs could identify as potentially being
inappropriate. Achieving these aims will provide stakeholders with information that can be used when making
decisions about whether to require prior authorization for tobacco cessation medications and, conditional on
requiring prior authorization, to set up systems and rules that improve the prior authorization process for
tobacco cessation medications. Achieving the aims of this study will address multiple research priorities of the
National Cancer Institute by increasing knowledge about barriers in access to evidenced-based cessation
treatments, by identifying strategies to increase the use of cessation treatments for people with low
socioeconomic status, and by providing insights into how insurers can contribute to tobacco cessation.

Public health relevance
PROJECT NARRATIVE – RELEVANCE Increasing access to tobacco cessation medications is a key part of U.S. health policy’s strategy for reducing smoking rates, especially for smokers with low incomes. The central objectives of this project are to estimate the impact of prior authorization requirements for tobacco cessation medications in Medicaid programs on the use of cessation-related health care treatment and to understand prior authorization’s implications for disparities in the use of tobacco cessation medications and for potentially contraindicated prescriptions. The findings from this study will provide public health stakeholders with information that can be used when making decisions about whether to require prior authorization for tobacco cessation medications and, conditional on requiring prior authorization, to set up systems and rules that improve the prior authorization process for tobacco cessation medications.